Novel Methods for Nicotinic Receptor Modulation in the Treatment of Post-Operative Pain

Project Summary/Abstract
Upwards of 50 million individuals are afflicted by chronic pain in the USA, with 3 million of these
individuals suffering from neuropathic pain, which can stem from known causes including surgical procedures,
injury, cancer, and HIV/AIDS. While opiates are a mainstay of analgesic use, they offer limited benefit to chronic
pain sufferers due to variable efficacy, serious adverse reactions and a high addictive potential. Thus, there is
renewed interest for developing non-opioid compounds with improved analgesic efficacy and reduced adverse
reactions. Nicotinic receptors (nAChRs) have been viewed as promising targets for non-opioid analgesics.
Specifically, α7 nAChRs offer an intriguing potential target for analgesic drugs. α7 agonists and positive allosteric
modulators (PAMs) have demonstrated robust analgesic efficacy in several rodent models of acute and chronic
pain. Chronic pain was recently shown to suppress acetylcholine levels in a descending pain modulatory center,
the ventrolateral periaqueductal gray area (vlPAG). This observation highlights the potential utility of PAMs, to
boost receptor activation via endogenous cholinergic tone and may reverse the cholinergic hypofunction
associated with acute and chronic pain states.
As allosteric modulators, PAMs offer an attractive solution to drug discovery based on the potential for
exquisite selectivity in modulating α7 nAChRs. Despite significant research the most promising PAM discovered
is PNU120596 (PNU). Epigen has developed a novel formulation suitable (EPGN2325) for its evaluation in
therapeutic applications. Recent data suggests an opportunity for its utility in post-surgical pain.
In this proposal, a two-pronged approach will be adopted. In the first, in collaboration with University of
Chicago (UC), EPGN2325 will be tested in pre-clinical models of chronic pain with the goal of establishing α7
nAChRs (and EPGN2325) as an approach to treatment of post-surgical pain. In the second, an approach to
develop an oral approach to post-surgical pain based on α7 nAChRs will be undertaken. In this approach Epigen
will conduct limited medicinal chemistry around PNU to resolve issues identified from ADME profiling for oral
use. A lead molecule from this effort will be tested in pain models at UC. Collective data will determine the utility
of α7 nAChR activation for pain management and if successful, identify a potential candidate for development.

Public health relevance
PROJECT NARRATIVE The management of pain following surgery remains an area of clear unmet medical need. This project seeks to discover and develop novel positive allosteric modulators (PAMs) of the 7 nicotinic acetylcholine (ACh) receptor (7 nAChR) with utility in models of post-operative pain to IND.